RNA modifications in apolipoprotein regulation by environmental exposures

Exposure to persistent environmental contaminants including polychlorinated biphenyls (PCBs) contributes to
metabolic diseases including metabolic dysfunction-associated steatotic liver disease (MASLD). Although PCB
exposures are positively associated with altered liver enzymes, miRNAs, MASLD, and mortality in human
cohorts, how PCBs act in collaboration with a high fat diet (HFD) to promote increased hepatic triglyceride
accumulation, fibrosis, and inflammation in progression to metabolic-dysfunction associated steatohepatitis
(MASH) remains unknown. Further, although liver sexual dimorphism and sex-specific differences in human
health outcomes after PCB exposure have been reported, few mechanistic studies have addressed these
differences. We reported that livers from HFD-fed male mice with MASH after a single oral exposure to an
environmentally-relevant mixture of non-dioxin-like PCBs, Aroclor1260 (Ar1260), and the dioxin-like PCB126
showed increased N(6)-methyladenosine (m6A), the most common RNA modification, that regulates transcript
stability and alternative splicing (AS). We identified m6A in Apob (apolipoprotein b) and other MASLD-related
transcripts using m6A mRNA immunoprecipitation (RIP)-sequencing and confirmed select m6A-differentially
expressed genes using Nanopore direct RNA-seq. in AML12 mouse hepatocytes. Reduced APOB protein is
critical for hepatic lipid accumulation in human MASLD. Apob is constitutively transcribed, suggesting that post-
transcriptional regulation and protein stability determine APOB levels. These data support our overarching
hypothesis that PCB exposures and diet alter m6A to regulate lipid metabolism pathways in MASLD. We address
a critical knowledge gap in how diet, environmental pollutant exposures, and sex modify the m6A
epitranscriptome to regulate apolipoprotein homeostasis. We will 1) Determine if the altered m6A marks in the
Apob transcript with PCB exposures regulate transcript stability and translation. 2) Determine how sex and diet
impact m6A marks in lipoprotein transcripts in a high fat, high fructose diet (HFHFD) + PCB exposure model of
MASH. 3) Identify the extent of m6A-induced alternative splicing (AS) in livers in HFHFD-fed mice with PCB
exposures. The resulting data will be the first to directly examine how mA6-containing Apob regulates protein
abundance affecting hepatic lipid pathology. Determining the mechanistic interplay of m6A, diet, and PCB
exposures in promoting NAFLD progression will reveal possible targets for therapeutic intervention.

Public health relevance
Environmental exposures to polychlorinated biphenyls (PCBs) increase progression of metabolic dysfunction- associated steatotic liver disease (MASLD) induced by a high fat diet. The mechanisms by which PCB-induced m6A modifications of apolipoproteins and alternative splicing impact MASLD is unknown. The goal of this study is to determine how m6A regulates transcripts resulting in sex-specific gene changes in MASLD.